Developmental Research Project

PROJECT SUMMARY/ABSTRACT of the Developmental Research Program (DRP)
The Developmental Research Program (DRP) will provide key support to rapidly advance new ideas that have
the potential to substantially impact our understanding of cancer disparities, and ultimately, will contribute to the
reduction in the morbidity and mortality of cancer among a racially and ethnically diverse population. Our DRP
has been structured to achieve the following Specific Aims:
1. Promote the development of innovative early-stage cancer disparities research projects spanning translational
research areas: molecular biology, epidemiology (primary and secondary prevention), risk prediction, early
detection, prognosis, therapeutics, and survivorship.
2. Encourage high-risk/high-payoff pilot projects to ensure our SPORE remains at the cutting edge of research.
3. Engage underrepresented minority investigators to lead early-stage research projects.
4. Provide funding, infrastructure, and mentorship to facilitate the feasibility and success of DRP projects.
5. Monitor the progress of funded projects and help advance them to become full SPORE or R type grants.
To achieve these Specific Aims, new ideas will be solicited on an annual basis by broadly advertising the
availability of our pilot funds and by directly engaging with promising investigators. We will encourage early-
career and established investigators to collaborate across disciplines. To ensure a rigorous and balanced
scientific review of DRP proposals, we will convene an expert panel encompassing a broad range of scientific
disciplines and include participation from our Community Advisory Board. Combined with our generous
institutional support, we will award $125,000 of funding to DRP projects annually and anticipate that each year
we will fund 2-4 projects. Funded DRP projects will receive strong infrastructure support, access to
biospecimens, data, and expertise related to novel technologies and statistical analyses through our
Administrative, Biospecimen and Pathology and Biostatistics and Bioinformatics Cores as well as training in
cancer disparities research as offered by the Career Enhancement Program. We will provide mentorship to all
DRP investigators to ensure long-term engagement with the TRPCD and its mission. The progress of all DRP
projects will be monitored regularly with respect to achieving their specific aims and milestones using clearly
defined evaluation criteria. We will also track long-term reportable outcomes of each project such as peer-
reviewed manuscripts, oral presentations, and grant funding. During our funded P20 SPORE planning phase we
have gained substantial expertise in conducting a successfully DRP that has been instrumental in supporting
new research areas leading to full SPORE projects as well as investigator-initiated R type applications
demonstrating our ability to develop a successful DRP and the tremendous importance of the DRP as part of a
strong multipronged Translational Research Program in Colorectal Cancer Disparities.

Public health relevance
PROJECT NARRATIVE of the Developmental Research Program (DRP) The Developmental Research Program (DRP) is a key component of the long-term success of our Translational Research Program in Cancer Differences across Populations. It will swiftly fund innovative and impactful DRP projects focused on translational cancer research with the potential to develop into full research projects. The DRP will be a catalyst to accelerate cutting edge cancer translational research that aims to understand the underlying biological drivers for cancer differences and develop interventions and treatments that will lead to reduction in the morbidity and mortality of cancer.